Antidote for inhaled CO poisoning based on mutationally engineered neuroglobin

Carbon monoxide (CO) poisoning remains a major cause of death and disability, affecting 50,000 persons each
year in the U.S. alone. Patients removed from fires or following exposure to car and home generator exhaust
are placed on 100% oxygen and transferred to a facility with a hyperbaric oxygen delivery system. Despite the
availability of hyberbaric therapy centers, inherent delays in access to and initiation of therapy greatly limit
efficacy. Even with hyberbaric oxygen therapy, 1-2% of patients die and >25% of surviving patients exhibit
neurocognitive impairments. There is currently no point-of-care antidote for CO poisoning available clinically.
In our initial work we discovered a surprising and near-irreversible CO-binding affinity of mutationally engineered
human neuroglobin (Ngb). Ngb is a six-coordinate hemoprotein, with the heme iron coordinated by two histidine
residues. We mutated the distal histidine to glutamine (H64Q) and three surface-thiols to form a five-coordinate
heme protein (Ngb-H64Q-CCC) that has very high solubility (>10mM), allowing for high concentration and
intravenous infusion. This molecule binds CO ≈ 500 times more strongly than Hb. Infusions of Ngb-H64Q-CCC
in CO-poisoned mice enhanced CO removal from red blood cells in vivo from 25 minutes to 25 seconds, restored
heart rate and blood pressure, increased survival from less than 10% to over 85%, and were followed by rapid
renal elimination of CO-bound Ngb-H64Q-CCC. These findings provided proof of concept that heme-based
scavenger molecules with very high CO binding affinity can be developed as potential antidotes for CO poisoning.
In the previous funding period, we continued the development of our Ngb-H64Q-CCC molecule, evaluating
efficacy on the restoration of cellular aerobic respiration, safety, and acute and long-term effects on
cardiovascular and cognitive function and survival in pre-clinical models, and scaling production of recombinant
protein for clinical development. We showed how infusion of Ngb-H64Q-CCC can restore mitochondrial
respiration in tissues and reverse CO-induced effects. We also set out to discover novel CO scavenger molecules
which may have improved properties over our lead molecule. Our studies uncovered that RcoM, a bacterial CO
sensor, has a high affinity towards CO and presents promising safety profiles in mouse models.
In the present proposal we plan to further develop our Ngb-H64Q-CCC molecule, adding modifications that
improve its CO affinity and stability for a safer toxicity profile. We also will engineer RcoM to obtain the smallest
unit that can scavenge CO with high affinity and present optimal stability and safety properties. Finally, we will
leverage all the knowledge on CO and oxygen binding achieved during our research program to develop novel
oxygen carrier molecules that can serve as blood substitutes.
Overall, these proposed studies are in keeping with the mission of the NHLBI and NIH to advance highly
impactful, significant, and novel studies that have great potential to improve the public health. Support for these
proposed studies has the potential to change our current paradigm for therapy of CO poisoning.

Public health relevance
Project narrative: Carbon monoxide poisoning results in an estimated 50,000 emergency department visits in the United States annually and is one of the leading causes of poisoning death. In the current proposal we aim to develop a specific antidotal therapy that can be given in the field by paramedics that can remove carbon monoxide from red blood cells, tissues, and heart and brain mitochondria within minutes. The availability of an effective antidote for carbon monoxide has the potential to dramatically change the current treatment and substantially decrease death and disability caused from this common poisoning.